Resource Center for Cannabis and Cannabinoid Research (R3CR)

PROJECT ABSTRACT
Conducting research involving cannabis or cannabinoids presents many challenges to scientists regarding
regulatory issues and the acquisition and utilization of materials suitable for valid scientific studies. To address
and rectify the major barriers and challenges to cannabis research, we will establish a resource center that will
provide research tools to the scientific community that will allow advances in cannabis science through both non-
clinical and clinical studies. The goal of this Center is to serve as a comprehensive resource to support
investigators involved or interested in cannabis research by providing guidance and information to help address
barriers and challenges related to regulations, research materials, and proposal development. The Center will
consist of three cores that will provide guidance through a centralized website as well as through workshops and
webinars. The Research Support Core will disseminate scientific and regulatory information, organize, and
convene webinars and workshops, and administer seed funding for registration support and proposal
development. The scoring criteria for seed funding award applications will include relevance to the interests of
the NIH IC sponsors. The Regulatory Guidance Core will establish a clearinghouse for policy guidance. The
Research Standards Core will provide guidance on cannabis research through a repository of best practices and
technical information. The Center will impact a broad range of stakeholders, including the scientific community,
federal and state agencies, institutional administrators, and suppliers of research materials. New cannabis
investigations fostered by our guidance will serve as incentives for others to enter the cannabis research field,
which may lead to novel research studies and licensing of more cannabis technologies as a clear regulatory
pathway develops. Investigators as well as research administrators will utilize our guidance tools to advance
their studies by gaining an improved understanding of regulatory requirements and best practices. The goals
and objectives of this proposal will be accomplished through these specific aims:
1. Promote widespread advancement of cannabis research by propagating guidance and resources to
investigators.
2. Reduce barriers to cannabis research by compiling and interpreting regulatory policies to benefit both the
investigators and the regulatory agencies.
3. Improve the reproducibility of research studies by providing guidance on investigational materials, quality
standards, practices, and metrics for quality research.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because many challenges currently exist in conducting cannabis research and more studies are necessary to help better understand both the beneficial and detrimental effects of cannabis use. This resource Center for cannabis researchers will help them overcome those challenges so they can generate valid scientific data.